TAS::75 0849:: Electronic Pathology Software Upgrades and Enhancements

This contract supports the upgrade and enhancements of electronic pathology software used by the Surveillance, Epidemiology and End Results (SEER) initiative managed by the Surveillance Research Program of the National Cancer Institute.